18th International Conference on Pseudomonas

PROJECT SUMMARY/ABSTRACT The International Pseudomonas Conference is a biennial event that brings together investigators from a full range of interdisciplinary and emerging fields from evolution of pathogenesis, sociomicrobiology, ecology of natural communities, biotechnology, vaccines, and synthetic biology from academia, pharmaceutical companies, and government, to discuss common issues and share approaches to promote exchange of ideas and share new technologies and develop fruitful collaborations related to the genus Pseudomonas. There are no other conferences that have similar themes, focusing on diverse scientific questions and including all species of this genus. The fact that this meeting is held in a different country every other year assures that each conference will have a distinctive flavor. Pseudomonas 2021 will be no exception. This meeting will be held in Atlanta, Georgia on September 27-October 1, 2021 at the Georgia Tech Hotel and Conference Center. This site was chosen was chosen to provide easy, worldwide access and to keep meeting costs as low as possible. The goals of the meeting will be: (1) To bring together investigators from diverse backgrounds to move the Pseudomonas field forward. This will be accomplished by the choice of invited speakers, who have been chosen for their diversity, expertise, collegiality, and breadth of interest. In addition to presenting their research seminar, each of the speakers has agreed to host “mentoring” tables during lunch each day in which seats are reserved for trainees to meet and interact them. This unique activity this will help break down barriers and also provide an exceptional networking experience for all the participants. (2) To train and mentor young investigators in the fields of Pseudomonas research and promote diversity within the research community. Since 80% of all session platform lectures will be selected from submitted abstracts, junior investigators, female researchers, individuals from underrepresented, racial and ethnic groups, people with disabilities and/or scientists with young children will be encouraged to submit abstracts for consideration. (3) To create an environment for collegial interactions and discussions between scientists in varying areas of Pseudomonas research by including additional opportunities for collegial discussions as well as group breakfasts and lunches, and poster sessions. Through such interactions, a venue is provided for the exchange of ideas and information. Our goal is to attract >300 participants to the conference who reflect the breadth and depth of this vibrantly active field and present the cutting-edge scientific breakthroughs that are on the immediate horizon. Both the co-chairs have organized similar conferences and an excellent set of speakers have already accepted invitations giving confidence that this meeting will be a success.

Public health relevance
PROJECT NARRATIVE The International Pseudomonas Conference, Pseudomonas 2021, will be held on September 27-October 1, 2021 in Atlanta, Georgia. This biennial event attracts researchers from a full range of interdisciplinary and emerging fields from evolution of pathogenesis, sociomicrobiology, ecology of natural communities, biotechnology, and synthetic biology. The goal is for these researchers from academia, pharmaceutical companies, and government to come together to share approaches and promote the exchange of ideas and share new technologies and develop fruitful collaborations across these various fields related to Pseudomonas.